Center for the Dissemination of Ultra-Long-Acting Antiretroviral Release Technology: DART Resource Program

ABSTRACT
Human immunodeficiency virus (HIV) is one of the top areas of the National Institutes of Health-
funded nonhuman primates (NHP) research. Within this context, antiretroviral (ARVs) used in research for
HIV pre-exposure prophylaxis and treatment require frequent dosing regimens. ARVs are often
administered through daily oral dosing or repeated injections, which are costly as well as burdensome on
animals, veterinary staff and operational resources. Moreover, inconsistency in dosing regimen or dosages
could be detrimental to research outcomes. Given this, we propose the dissemination of a drug-agnostic
ultra-long-acting subcutaneous drug delivery implant, the NanoDDI, as a research tool for NHP studies,
through the Center for the Dissemination of Ultra-Long-Acting Antiretroviral Release Technology: DART
Resource Program. The DART Program will provide the NanoDDI for use in NHP studies on HIV for long-
term ARV release to replace conventional modes of administration. Sustained and constant ARV delivery
from the NanoDDI is achieved through controlled drug diffusion across a nanofluidic membrane without
pumps or ports. The NanoDDI technology is immediately ready for use and rapid and reproducible
manufacturing permits widespread facile dissemination. The drug-agnostic technology is supported by 10
years of development and deployment in various animal models, with demonstrations of long-term
sustained release of various ARVs in NHP for up to 29 months without interruption. The central tenet of the
HIV-related NHP studies and alleviate animal, operational and financial burden associated with conventional
administ ation methods. The aims of the proposed DART Program, which will be pursued concurrently over five
DART Program is that the NanoDDI can standardize ARV delivery across wide-ranging
years, are, Aim 1: Outreach and Dissemination of NanoDDI for HIV Research in NHP, Aim 2: Integration and
Deployment of NanoDDI for ARV Delivery in Independent Users’ Laboratories, and Aim 3: Broaden the Spectrum
of Applicability of NanoDDI within the HIV Research Community. Outreach initiatives will create awareness and
promote adoption of the NanoDDI into current and future NHP HIV research. The DART Program will ensure
standardized NanoDDI deployment in Users’ NHP studies for reproducible research outcomes through
comprehensive training, supported by our research and veterinary staff, and Veterinary Scientific Advisory board.
Concurrently, User-generated data and User-introduced novel ARVs could enhance outreach as well as broaden
NanoDDI drug portfolio. Altogether, research outcomes and dataset generated inclusive of ARV pharmacokinetic
and User-specific data, could be used to fill knowledge gaps, improve drug delivery and accelerate drug
development in HIV research. Expected outcomes of the DART Program include: successful integration of the
NanoDDI into NHP HIV studies with significant cost and burden reduction, increase research output due to cost-
and time-efficient changes in ARV delivery protocols, higher quality research data due to less variability in ARV
delivery, and minimize scientific and financial risks associated with NHP research.

Public health relevance
Project Narrative Nonhuman primates (NHP) are important for human immunodeficiency virus (HIV) treatment and prevention research. The DART Program aims to broadly disseminate a long-acting drug-agnostic delivery implant for sustained antiretroviral administration in NHP HIV research. The implant enables long-term constant and sustained drug release in a reproducible manner, which will enhance experimental rigor and reproducibility as well as animal well-being, and minimize costs and resources related to repeated dosing procedures typically required for antiretrovirals.